Curation Expert Panels for BRCA1/2 and Hereditary Breast, Ovarian and Pancreatic (HBOP) Cancer Genes

PROJECT SUMMARY
Individuals with germline variants in breast, ovarian and pancreatic cancer predisposition genes are at
significantly elevated risk of developing these cancers in their lifetime. Clinical hereditary cancer genetic testing
for pathogenic variants in these genes has become an important part of clinical practice. Much of the benefits of
genetic testing are associated with the BRCA1 and BRCA2 genes because of the risk management, surgical
prevention and targeted treatment benefits associated with knowledge of the presence of a cancer predisposing
pathogenic variants. However, identification of pathogenic variants in other predisposition genes including ATM,
BARD1, BRIP1, CHEK2, PALB2, RAD51C and RAD51D is also clincially meaningful because carriers may
qualify for enhanced screening for breast, ovarian and pancreatic cancer. However, this process is often
complicated by an inability to establish the clinical relevance of variants in these genes. This lack of information
about these variants means that individuals carrying germline variants often cannot benefit from enhanced risk
assessment and management or make informed decisions about surgical prevention or tailored treatment
options. To address this issue, we developed the BRCA1/2 and Hereditary Breast, Ovarian, and Pancreatic
(HBOP) Variant Curation Expert Panels (VCEPs). We will build upon our initial work to implement ClinGen rules-
based methods for variant classification in BRCA1, BRCA2, ATM and PALB2 and also develop and implement
rules for curation of variants in CHEK2, RAD51C, RAD51D, BARD1 and BRIP1. Thus, the goal of this application
is to curate and classify the clinical relevance of germline variants in BRCA1 and BRCA2 through a
BRCA1/2 VCEP and variants in ATM, BARD1, BRIP1, CHEK2, PALB2, RAD51C and RAD51D through the
HBOP VCEP. The results from the proposed curation efforts will be entered into the ClinGen Variant Curation
Interface and made available to the public through the ClinVar and BRCA Exchange websites.

Public health relevance
PROJECT NARRATIVE The catalogs of variants in the BRCA1, BRCA2 and Hereditary Breast, Ovarian and Pancreatic (HBOP) cancer genes that will be established as pathogenic/likely pathogenic or benign/likely benign are expected to greatly impact clinical management of individuals diagnosed with variants in these cancer genes.